Task Area A shall encompass annual follow-up of cohort members, clinical events investigations, study operations, and data analysis and manuscript writing. If implemented, Task A.1 will provide fundin

The Multi-Ethnic Study of Atherosclerosis (MESA) is a study of the correlates, predictors, and progression
of subclinical cardiovascular disease (CVD) in a diverse population-based sample of men and women
aged 45-84 who had no evidence of clinical CVD at baseline. During the initial funding period of MESA,
6,814 participants were recruited from six Field Centers during 2000-2002 and examined for evidence of
subclinical coronary atherosclerosis, using computed tomography, cardiac MRI, carotid ultrasound, flowmediated
brachial artery dilation, radial artery tonometry, ankle-brachial index measurement, and retinal
photography. A number of other variables including abdominal aortic CT, carotid MRI, cardiac MRI
tagging for measures of regional myocardial function; established and putative laboratory risk markers;
socioeconomic, psychological, behavioral and environmental characteristics; and genetic variants were
assessed in subsets of the MESA cohort. Examinations of selected components were repeated over five
subsequent examinations spanning approximately 16 years and the cohort has been continuously
followed for clinical CVD events since the baseline examination.
The study will continue to support in-depth ancillary studies that are funded outside of the NHLBI contract.
These studies will be operationally integrated into the main study, and the data will be shared across the
entire “MESA Suite” of studies, per current MESA and NIH data-sharing policies. The study’s data will be
provided to interested investigators through a defined process that encourages maximum data utilization
while protecting participant confidentiality.